The Annual Food Safety and Defense Conference, held in the District of Columbia, is an educationalconference and collaborative effort with stakeholders in the District.

Food Safety Task Force
899 North Capitol St NE
Washington DC, 20002
Phone: (202) 535-2339 Fax- (202)535-1359
Email:[email] Website:http:www.doh.dc.gov
April 12,2023 October 12,2024
In an effort to reduce the incidence of foodborne illnesses in the Washington, DC
metropolitan area, the Food Safety Task Force Advisory Committee (FSAC) was formed. The
Committee is comprised of members from local, state and federal level government agency
representatives, industry representatives, and academia. To support the efforts and
successful initiatives of this committee, the FSDAC seeks funding from the U.S Food and
Drug Administration in the amount of $42,600.
Through the Annual Food Safety Conference, regular membership meetings, surveying the
needs with the overall community, and community outreach, the FSTF will work to bridge
the of knowledge between industry and government regulation, work to change behaviors
in a positive direction, and build a strong foundation for future community leaders in that
area of food safety. In the time of the pandemic the task force had to adopt virtual meeting
platforms. Post pandemic we will continue with a virtual aspect of the conference as well as
in person. This will allow those that are not able to travel to the conference to view on live
stream

Public health relevance
Attac1h-mPernotNjarercattive Introduction ThDeistorfCiolcutmb(iDoaCr"DstiriDcetp"ar)tomfeHneatl(tDhHO)HelatRhegulnatio LicnesiAndgminis(trHaRtLiFAoo)no,SdatfeyanHdygnieIenspecSetrivoiDncievsision (FSHIseSeDkfu)sndinogf$42,fr6o0mt0hUenitSeatdtFeosoanddDrguAdminisatsration, part oftheFooSdafTeatsyFokr(cFeSTaFn)IdntegPrraotjGeerdcanPttrogram(R13) ProjNeacrtrative Pag7ePag7e ProjNeacrtrative